Database and Statistical Core

PROJECT SUMMARY
The Database and Statistical Core (DBSC) provides comprehensive data-related services for all
Conte Center projects and cores, including research design, statistical consultation and
manuscript review, data system development and implementation, quality assurance, data
security and backup. Specifically, the intention is that the DBSC will: 1) Provide the highest level
of statistical consultation to all Center investigators at all stages of each of the six proposed
research projects; 2) Establish state–of-the-art data management services and ensure close
coordination of staff responsible for each component database (clinical, psychological autopsy,
MRI, PET, genetic/epigenetic, and animal); 3) Enforce rigorous protocols to ensure data integrity,
quality and confidentiality; 4) Prepare well documented data sets for all planned and ad hoc
analyses, integrating data elements as needed from each of the component databases and
developing algorithms for the creation of derived variables; 5) Conduct all required data analyses
and participate in preparation of manuscripts for publication; 6) Develop and implement innovative
applications of statistical techniques and data processing for suicide research. Notable resources
available to the DBSC in achieving these goals include a) the staff and facilities of the Columbia
Mailman School of Public Health (MSPH) Biostatistics Department, where two DBSC members
have faculty appointments and b) the staff and information technology resources of the New York
State Psychiatric Institute (NYSPI)/Columbia MSPH Data Coordinating Center, headed by Dr.
Howard Andrews, who is co-PI of the DBSC. Because of the highly sensitive nature of the data
collected in this project, and increasing concern regarding electronic data breaches, state-of-the-
art procedures are in place to safeguard Conte Center data from the point of data collection and
entry, through database storage and backup, to the generation and use of analytic files for report
generation and statistical analysis. To ensure that future as well as current challenges to data
security are addressed, the DBSC is in constant communication with the NYSPI PsyIT
department, and the Columbia University IT Department-Security Division.